Antibiotics, innate immunity, and dysbiosis in pediatric urticarial reactions

Project Summary
Antibiotic associated reactions (AAR) occur in 5-10% of children and cause substantial distress to families due
to the occurrence of rashes, swelling of the face/hands/feet, fever, and gastrointestinal upset. When hives and
joint pain are both present, reactions are labeled as serum sickness like reactions (SSLR), a bothersome reaction
due to prolonged, uncomfortable symptoms and lack of response to allergy medications such as antihistamines.
Recently, it has become apparent that AAR (including SSLR) are rarely reproduceable (<5%) with re-exposure
to the antibiotic in an allergist office. Research studies are needed to identify what causes AAR to occur in the
first place and whether antibiotics may play a role in reactions without evidence for classical allergic
hypersensitivity reactions. We have recently observed that children may experience repeat episodes of hives
and SSLR despite non allergic testing and despite interval tolerance of the antibiotic. The reactions are delayed
in onset and unpredictable. We hypothesize that prolonged use of antibiotics induces gut dysbiosis which leads
to autoinflammatory reactions in susceptible children. To test this hypothesis, we plan a multi-omics approach,
evaluating inflammatory blood markers, immune transcriptomics, fecal microbiota populations and metabolic
derangements. We will associate the multi-omics assessments with 2 cohorts of children- those experiencing
typical, short lived, antihistamine responsive urticaria and those affected by hives that are atypical- poorly
response to antihistamines, prolonged in duration, and associated with painful swelling of joints and extremities.
To characterize these 2 urticarial reactions as distinct subsets (not currently defined clinically), we will collect
additional clinical information to establish pattern recognition in each cohort. This will include patient recorded
outcome measures of urticarial symptoms, medication usage and response, photo documentation of rashes with
dermatology confirmation and ultrasound-based assessment of joints for evidence of synovitis. Using
computational modeling, we will determine which biomarkers associate strongly to one cohort versus the other
cohort. We will accomplish our aims by engaging a multidisciplinary team of allergy/immunology/ rheumatology/
dermatology/infectious disease physician investigators and computational and metabolomics experts.
Many children will experience urticarial reactions while taking antibiotics and will presume they are allergic. This
study will help identify the scientific basis for occurrence of hives without evidence for classically defined allergy
responses, including the possibility that antibiotic disruption of healthy commensals leads to autoinflammatory
reactions in susceptible hosts. By identifying novel mechanisms whereby antibiotics lead to urticarial reactions
and associating them to well defined, clinical syndromes, we may prevent the accumulation of unnecessary
allergy labels and identify effective treatment of children who experience severe reactions such as SSLR.

Public health relevance
Project Narrative Allergic symptoms like hives, swelling, fever or joint pain occur in 5-10% of children who take antibiotics for common infections. Children who experience these symptoms are rarely allergic when tested by drug challenge. This study aims to identify the reasons why some children develop bothersome reactions and others do not.